USE OF ELECTROPHYSIOLOGIC STUDIES TO GUIDE THERAPY FOR NSVT

The objective of the proposed study is to test the hypothesis that by treating the highest risk group of patients (those with coronary artery disease, left ventricular ejection fractions <40, spontaneous nonsustained ventricular tachycardia and inducible sustained ventricular tachycardia) with antiarrhythmic therapy guided by electrophysiologic studies, the risk of sudden arrhythmic death and spontaneous sustained ventricular tachycardia can be reduced.